CORE--DEVELOPMENTAL FUNDS

Description: Developmental funds are requested to 1) support the recruitment of new KCC investigators with specific expertise in Structural Biology, Developmental Therapeutics, Genito-Urinary Cancer, and Breast Cancer, and 2) for the development of two new shared resources - a Microarray Facility and A Molecular Cytogenetics and Diagnostics Facility.